MOLECULAR STUDIES OF OVARIAN CANCER AND THE WNT PATHWAY IN HUMAN CANCER

These studies focus on two topics: ovarian cancer and the Wnt pathway in human cancers. Ovarian cancer is the fifth most common cancer and the fourth leading cause of cancer death among women in the United States. Because of a lack of powerful screening and diagnostic tests, early detection has been difficult. Moreover, the molecular mechanisms involved in the initiation and progression of ovarian cancer remain largely unknown. We are using SAGE and other state-of-the-art molecular techniques to identify tumor markers and gain a greater understanding of the molecular pathways involved in ovarian tumorigenesis. In addition, we are interested in a region on the X chromosome, which is frequently lost in high grade ovarian cancers, suggesting the presence of a tumor suppressor gene involved late in ovarian tumor development. We have now found that the gene involved may be the growth-regulatory gene for glypican 3 (GPC3). This work suggests that GPC3 is involved in the growth regulation of the normal ovaries and that its deregulation can contribute to ovarian neoplasia.The Wnt pathway, which was originally defined as a crucial pathway for body patterning during fruit fly development, has recently been implicated in human cancer. APC, a gene mutated in 80% of all colon cancers, is involved in the downregulation of the Wnt pathway. Moreover, colon tumors containing wild-type APC, frequently contain activating mutations in other members of the pathway emphasizing its importance for colon cancer progression. We are developing inducible systems that may be useful in the identification of downstream transcriptional targets as well as upstream regulatory components of the pathway . - Cancer, Ovarian, Molecular, SAGE, Catenin, APC, Tumorigenesis, Pathway, Wnt, Genetics